Gene Expression Database for Mouse Development

Abstract – OVERALL COMPONENT
The goal of this application is the continued development and maintenance of the Gene Expression
Database for Mouse Development (GXD). GXD is a well-established community resource. It integrates
different types of expression data including biologically complex data, such as RNA in situ hybridization and
immunohistochemistry results, and high-throughput expression data from RNA-seq experiments. It places
these data in the larger biological context through integration with other Mouse Genome Informatics (MGI)
resources and interconnections with many other databases, supporting complex queries that enable thorough
biological and computational analyses.
The specific aims of this proposal are (1) to continue and expand GXD’s curation of expression data and
anatomical ontologies and ensure high-quality data annotation and integration. We will continue to
curate data from RNA in situ hybridization, in situ-reporter knock-in, immunohistochemistry, RT-PCR, Northern
blot and Western blot experiments; and expand our annotation of bulk and single-cell RNA-seq data sets. We
will enhance the mouse anatomy ontology, and refine our expression annotations by combining anatomy and
cell type terms. We will (2) maintain the GXD database and enhance GXD’s infrastructure and data entry
interfaces to accommodate large volumes of expression data and to represent new types of data and
relationships. We will enhance the database and software infrastructure to accommodate the expected
increase in RNA-seq data. We will expand the database to represent anatomical differentiation pathways, as
well as expression annotations to cell type terms. We will continue to modernize the editorial interface and
expand the interface as needed for the annotation of new data types. We will automate more steps of the
literature selection process to increase curation efficiency. We will (3) continue to evolve GXD’s user
interface and develop advanced query and display tools. We will develop expression searches that allow
the analysis of anatomical differentiation pathways and cell types. We will add support for quantitative
expression analyses, comparisons and profiling. We will develop displays that superimpose expression data
with molecular pathway and protein interaction data to support the analysis of molecular networks with co-
expression information. We will (4) provide user support and promote use of GXD by the scientific
community. We will continue to provide training and to solicit feedback on how we can improve GXD.

Public health relevance
Project Narrative/Relevance to Public Health The Gene Expression Database for Mouse Development (GXD) allows the scientific community to examine patterns of gene expression, elucidate biologically important molecular networks, and explore the genetic programs that underlie normal development and disregulations of development leading to human birth defects, to cancer and to many other diseases.